“Neural Stem Cells for Spinal Cord Injury: Studies leading to an IND”

We propose to advance a clinical program of neural stem cell therapy for spinal cord injury (SCI)
to an IND submission and clinical trial.
Our work to date has demonstrated that Neural Progenitor Cells (NPCs) and Neural Stem Cells
(NSCs) survive grafting to the spinal cord and extend very large numbers of axons over long
distances through the lesioned rodent and large animal spinal cord. Host axons also regenerate
into cell grafts occupying the lesion site, and form new synaptic connections that act as neural
relays across the injury to support functional improvement in both rodents and large animals.
We have identified a lead candidate human NSC/NPC line for clinical translation: an H9 human
embryonic stem cell (a federally approved human cell line) that is driven to a spinal cord
NSC/NPC fate. We refer to these cells as H9-scNSCs. H9-scNSCs survive grafting to cervical
spinal cord hemisection and contusion lesions. This promising line of work is advancing on a
translational path, supported extensively by the VA’s RR&D Gordon Mansfield Spinal Cord
Injury Consortium. We aim to bring this work to the point of readiness for human clinical trials in
SCI.
The goal of the current application is to advance this program to submission of an FDA IND,
with the eventual goal of a human clinical trial of this promising approach. For the 4 year funding
period, this project will support characterization of cells, assay development, IND-enabling in
vivo studies, project management and the services of regulatory experts with experience in FDA
submissions.

Public health relevance
Numerous veterans are living with spinal cord injury. Our program aims to develop a neural stem cell (NSC) therapy to repair the injured spinal cord and support func>onal recovery. The goal of the current applica>on is to complete ﬁnal pre-clinical studies that will allow us to apply to the U.S. Food and Drug Administra>on (FDA) to begin human clinical trials.